ULTRAHIGH PERFORMANCE MASS SPECTROMETER

This proposal is for purchase of an ultrahigh performance mass spectrometer for shared use primarily by Ohio State University faculty holding combined N.I.H. annual operating support of $1,987,972, for experiments that are not feasible with existing mass spectrometers on campus (see Project Description). The preferred instrument is a Fourier transform ion cyclotron resonance mass spectrometer, configured to include: 3 tesla superconducting solenoidal magnet, differentially pumped dual- cell, external electron source, array processor, Nd/YAG laser (including oscillator/amplifier and frequency doubler) and interface, and gas chromatograph and interface. The instrument will be shared among several research groups, for applications including (see Project Description): low-volatility compounds (all users), laser desorption/ionization (all users), ultrahigh mass resolution (Floss), MS/MS for ion structure determination (all users), gas-phase basicities and acidities (Paquette), and qualitative and quantitative analysis of heart drugs and their metabolites (Reuning, Robertson). The instrument will be operated on a service basis, and regular users from each research group will be trained for self-operation. The instrument will be installed maintained, operated, and updated by the OSU Campus Chemical Instrument Center (A.G. Marshall, Director).